Role of sialoglycan binding in the pathogenesis of streptococcal endocarditis

PROJECT SUMMARY
The oral streptococci are a major cause of infective endocarditis (IE). Several of these species express Siglec-
like, serine-rich repeat (SRR) adhesins that bind a variety of O-linked sialoglycans on human glycoproteins and
cells. Expression of the SRR adhesin GspB of Streptococcus gordonii M99 results in increased virulence in
animal models of IE. This enhanced pathogenicity is thought to be due the interaction of GspB with the
trisaccharide sialyl-T antigen (sTa, a core 1 sialoglycan) on the platelet receptor GPIb, leading to increased
attachment of bacteria in the blood stream to cardiac valve surfaces and vegetation formation. Isogenic
mutants of M99 expressing GspB variants that preferentially bind core 2 sialoglycans,(e.g., sialyl-lactosamine)
are less virulent, as compared with the WT strain. These findings indicate that differences in the type of
sialoglycan bound ("selectivity") affect the ability of organisms to both initiate and propagate endocardial
infection, with some interactions enhancing pathogenesis, while other interactions reducing disease. We
hypothesize that in vivo, the binding of streptococci in the bloodstream to sTa on platelets or cardiac surfaces
helps initiate infection, and that this binding is enhanced by hemodynamic effects created by high shear flow.
In contrast, binding to core 2 sialoglycans on blood cells may lead to increased bacterial clearance, thereby
attenuating virulence. Subsequent interactions of bacteria on valves with core 1 versus core 2 sialoglycans
may affect disease progression via different effects on platelet activation, clotting, or endothelial healing.
To further address the roles of sialoglycan binding selectivity in the pathogenesis of IE, we will compare by flow
the above isogenic strains for their binding to platelets, RBCs and WBCs in vitro. We will also examine whether
these strains bind platelets that differ in GPIb sialoglycan content, and whether binding to sTa versus core 2
structures affects platelet activation. In addition, we will assess how selectivity impacts the attachment of
bacteria to damaged cardiac surfaces, as modeled by microfluidic chambers lined with immobilized platelets,
von Willebrand Factor, collagen or activated human vascular endothelial cells, and the effect of hemodynamic
forces on binding. We will also explore the impact of selectivity on vegetation formation by assessing strain
differences in triggering platelet contractility and effects on platelet-dependent endothelial healing. We will also
compare vegetations produced in vivo by these strains for key features linked to virulence, including co-
localization with platelet and biofilm production.
These studies will provide novel insights as to how sialoglycan selectivity and hemodynamic forces affect the
initiation and propagation of endocardial infection. By defining the mechanisms for these events, this research
will redefine our understanding of the key steps in the pathogenesis of streptococcal IE. These concepts and
findings will be broadly applicable to other endovascular pathogens, and will provide novel insights into
microbial interactions with host glycans.

Public health relevance
PROJECT NARRATIVE This project explores the mechanisms by which streptococci produce endocarditis, a life-threatening infection of heart valves. It examines the complex interactions of these bacteria with sialoglycan sugars on host cells and proteins, and how these events are affected by the high flow conditions within the heart. This research will provide important scientific insights about how endocarditis is produced, and may lead to novel therapies.